BH3 Profiling in AML to Measure Apoptotic Signaling Kinetics of Approved Drugs and Identify Integrated Stress Response Apoptotic Susceptibilities

Acute myeloid leukemia (AML) is a devastating hematologic malignancy with poor outcomes and is characterized
by uncontrolled proliferation of immature myeloid blasts, cytopenia, infections, and bone marrow failure. Although
AML can present in individuals of all ages, AML is more frequently diagnosed in elderly individuals where the
median age at diagnosis is 68. Intensive “7+3” combination chemotherapy (cytarabine + daunorubicin) was
adopted five decades ago and remains the standard of care. Cytotoxic therapies induce apoptotic signaling that
converges on mitochondrial-localized BCL-2 family proteins that constitute pro-apoptotic (e.g., Bax, Bak, BH3
only proteins) and anti-apoptotic (e.g., BCL-2, MCL-1, Bcl-xL) members. The balance between pro-apoptotic and
anti-apoptotic BCL-2 family proteins controls mitochondrial outer membrane permeabilization and apoptosis.
Leveraging the unique biology surrounding programmed mitochondrial apoptotic cell death, we developed
dynamic BH3 profiling (DBP) to measure mitochondrial apoptotic priming and the extent anti-cancer drugs induce
apoptotic signaling. Using DBP, we previously identified a targetable BCL-2 dependency in AML and
demonstrated the potent anti-leukemic properties of the BCL-2 inhibitor venetoclax. These findings supported
the initiation of successful clinical trials that led to venetoclax approval in combination with low-dose cytarabine
or hypomethylating agents (azacitidine or decitabine). However, incomplete responses and resistance due in
part to reduced apoptotic priming is a clinical challenge. Thus, an improved understanding of apoptotic signaling
is necessary to inform treatment strategies and identify actionable therapeutic vulnerabilities.
Although combination therapies are the backbone of AML induction therapy, no study has systematically
evaluated apoptotic signaling kinetics to inform the timing of approved AML drugs. Preliminary data
demonstrated that different anti-cancer drugs induce variable apoptotic priming kinetics. As apoptotic priming
predicts in vivo therapeutic efficacy of cancer drugs, knowledge of priming kinetics may enhance the efficacy of
existing drugs. Moreover, I showed in the F99 phase that the integrated stress response (ISR) modulates
venetoclax cytotoxicity in AML. The ISR is an evolutionarily conserved process used by cells to regulate protein
synthesis and adapt to environmental or pathogenic stressors. ISR activation can paradoxically serve pro-
survival or pro-death functions in a context-dependent manner. I demonstrated that ISR inhibition with ISRIB
blunted venetoclax cytotoxicity in AML cells. These data suggest an interplay between the ISR and apoptotic
signaling which remains incompletely understood. Thus, in the K00 phase I will use DBP to 1) measure the
apoptotic signaling kinetics of approved AML drugs to inform optimal combination timing, and 2) evaluate the
relationship between apoptotic signaling and the ISR in AML. Our overarching hypothesis is that elucidating
apoptotic priming kinetics of approved AML drugs and understanding the interface between apoptotic signaling
and the ISR will enhance existing drug combinations and identify ISR-linked vulnerabilities.

Public health relevance
Acute myeloid leukemia (AML) is a devastating malignancy with poor outcomes despite the approval of multiple targeted therapies which highlights the need to develop improved treatment options. Apoptotic signaling surrounding AML drugs and the integrated stress response is incompletely understood, and an improved understanding of this signaling could support current treatments. The K00 phase of this application leverages dynamic BH3 profiling to define apoptotic priming kinetics of approved AML drugs to enhance drug combination timing (Aim 1) and identify integrated stress response-related therapeutic vulnerabilities in AML (Aim 2).